A mobile sensing system to monitor symptoms during chemotherapy

Abstract
The aims of the parent R37 grant were (1) to develop and refine a mobile sensing system that
applies machine learning to smartphone and wearable sensor data to passively detect symptom
burden during chemotherapy and (2) to evaluate the feasibility and acceptability of using this
system in an academic oncology clinic. Since the start of the R37 award on July 1, 2019, we have
enrolled 154 (77% of our target n = 200) patients into a 90-day study assessing daily and weekly
symptoms and continuous behavioral sensing via wearable device and smartphone during
chemotherapy, conducted interim analyses demonstrating that next-day overall symptom
burden can be predicted from passive sensor data, and developed infrastructure to deploy
symptom prediction models in real-time.
The next logical step for the original R37 research is to integrate sensor- and machine learning-
based predictions into a patient-centered digital health intervention to personalize supportive
cancer care. The two-year extension will enable us to design and develop a web application that
shares real-time symptom predictions with patients and uses them to trigger personalized
symptom management instructions. To provide useful recommendations, we also need to
develop prediction models that can predict specific, clinically significant and actionable
symptoms rather than overall symptom burden. In addition, we need to determine the best way
to share machine learning-based predictions and recommendations in a way that fosters trust
and that supports patient autonomy as well as patient-provider communication. The R37
extension will enable us to address two new aims: (1) develop additional machine learning
models to predict specific clinically meaningful and actionable symptoms and (2) design and
develop a web application that integrates these predictions and uses them to inform real-time
symptom management.
This work falls well within the scope of the parent grant and represents continued refinement of
both the clinical utility of our machine learning models as well as our integration of these
models into supportive cancer care within an academic oncology clinic.

Public health relevance
Public health relevance: Symptoms during cancer treatment are common, compromise patient quality of life and ability to tolerate treatment, and often go undetected at clinic visits. This project aims to combine smartphone and wearable sensor data with machine learning to remotely monitor symptoms during chemotherapy and to develop a system that automatically recommends patient-provider contact when severe symptoms are detected.